Signaling Scaffolds for Specificity in Neuromodulator Action

Abstract
b2-adrenoceptor signaling is critical for adrenergic regulation of synaptic plasticity and neurodegeneration, and
has been proposed to have therapeutic potentials for Alzheimer’s and Parkinson’s diseases. However, b-
adrenoceptors (b-ARs) exhibit highly complicated pharmaceutical effects. This is exemplified by clinical results,
in which b-AR drugs modulate receptor paralogs in different organs to elicit both therapeutic and clinically
harmful effects at the same time. We aim to understand the signaling specificity of b2-adrenoceptors (b2-ARs),
mechanisms through which they are selectively coupled to different intracellular signaling proteins and
molecular effectors under different conditions. Our published and preliminary results manifest the signaling
scaffold, synapse-associated protein of 97 kDa (SAP97) as an orchestrator of b2-AR signaling in hippocampal
neurons. Specifically, the b-isoform of SAP97 (S97b) tethers b2-ARs and the effector voltage-gated potassium
channel subunit Kv1.1 together to transduce activation of b2-AR signaling into inhibition of Kv1.1 and its removal
from the dendrite surface (collectively referred to as Kv1.1 inhibition). Consequently, b2-AR-induced Kv1.1
inhibition increases dendritic excitability and lowers the induction threshold for long-term synaptic potentiation.
Given b2-AR-signaling also regulates the phosphorylation of the AMPA receptor subunit GluA1, but through a
different signaling scaffold, we hypothesize that signaling scaffolds mediate the signaling specificity and the
interactions can be used as specific pharmacological targets. In this proposal, using the S97b/b2-AR/Kv1.1
complex as an exemplary model, we aim to gain mechanistic insights into a) how the diverse b2-AR signaling
events are specifically regulated; b), what the molecular components of the S97b/b2-AR/Kv1.1 complex are to
achieve signaling specificity; and c) what are the behavioral correlates of the S97b/b2-AR/Kv1.1 signaling pathway
in mice. Importantly, in SAP97-lacking neurons, the signaling pathway governing b2-AR dependent dendritic
excitability is impaired with a ~100% penetrance, allowing an analysis with minimal confounding effects of
functional redundancy. The outcomes of our proposed experiments will provide a set of mechanistically clear
drug targets for treating psychiatric, neurological, immunological or cardiovascular disorders, and perhaps more
importantly lead to a novel and generalizable molecular scheme, through which G-protein-coupled receptors
achieve biased and selective regulations of specific effector proteins to modulate synaptic transmission and
plasticity.

Public health relevance
Narrative Neuromodulators change the state of neural circuits to alter how they respond to extrinsic signals. The current application aims to understand how signaling scaffolds achieve signaling specificity by linking G- protein coupled receptors with the signaling machinery and downstream effector proteins. Using SAP97- regulated b2- adrenoceptor- mediated Kv1.1 inhibition in CA1 pyramidal neurons as a heuristic cellular model, we aim to identify the molecular underpinnings of signal transduction, mediating facilitation of long- term synaptic plasticity induction for specific forms of hippocampus- dependent learning.